Rodent Genetic Engineering Laboratory Shared Resource

Abstract/Project Summary
RODENT GENETIC ENGINEERING LABORATORY SHARED RESOURCE (RGEL)
The Rodent Genetic Engineering Shared Resource Laboratory (RGEL) is a new PCC Shared
Resource that offers innovative, comprehensive rodent genetic engineering services that
include: CRISPR/Cas9-mediated production of mutant mice, generation of transgenic mice by
pronuclear injection of DNA or BAC-DNA, gene targeting in mouse C57BL/6 embryonic stem
(ES) cells, generation of fully ESC-derived mice using tetraploid complementation and chimeras
with genetically altered ES cells, isolation and establishment of genetically-modified ES cells
from existing strains for serial gene targeting, and re-derivation and cryopreservation services
for both embryos and sperm. Under the direction of Dr. Sang Yong Kim, who has extensive
experience in mouse developmental biology and all aspects of manipulation of the mouse germ
line, RGEL is used extensively by PCC investigators to make novel genetically engineered
mouse models of cancer (GEMMs), as well as to rederive and store various mouse strains.
RGEL accomplishes its goals by means of four Specific Aims: Aim 1) To develop and apply
state-of-the-art technology and expertise in support of rodent genetic engineering; Aim 2) To
provide highly efficient, cost-effective services in DNA pronuclear injection, gene editing using
CRISPR-Cas9 and related systems, blastocyst injection (ES cell, iPS cell), ES cell gene
targeting and expansion, embryo tetraploid complementation, embryo rederivation, embryo &
sperm cryopreservation, in vitro fertilization (IVF) and transgenic animal genotyping; Aim 3) To
leverage expertise in experiment genetics, cell/molecular research and systems biology for
genotypic/phenotypic analyses; Aim 4) To provide scientific leadership for a collaborative center
of service, technology and expertise in experimental genetic mutation resources.